Developing a Blueprint to Implement Whole Health Clinical Care for Veterans with HIV

PROJECT SUMMARY
Background: VA's Office of Patient-Centered Care and Cultural Transformation's Whole Health (WH)
Implementation Guide states: "Whole Health should not be isolated to one specific service line, but instead is
the transformation of care in every service line within a VA facility." Yet, the current implementation efforts are
focused on primary and mental healthcare service lines. Specialty care plays an important role in the WH
System of Care, particularly for Veterans who receive a preponderance of care outside primary care. HIV
specialty care is a case in point. Because of the history of HIV, many Veterans with HIV get both specialty and
primary care consolidated in their HIV clinics, thus potentially limiting their exposure to WH. Further, a WH
approach may be particularly valuable for these Veterans because of their combined challenges of aging,
comorbidities and unique social circumstances, including living with a disease intertwined with blame, stigma
and marginalization. Thus, HIV specialty care clinics provide an exemplary case to further develop WH
implementation guidance for specialty care services.
Significance: Implementation guidance on specialty care’s role in the WH System of Care has yet to be fully
developed. Primary care-based implementation relies on WH champions, training, leadership support and
system strategies to address Veterans’ unique care plans, including coordination across services. Like other
specialty care services, the structure of HIV care is vastly different from large, integrated primary care teams. A
plan for WH implementation in specialty care settings is thus needed.
Innovation & Impact: Implementation plans, co-developed with end users, attend to contextually situated
needs and are more likely to be successful. This proposal leverages the expertise of Veterans with HIV, HIV
providers and leadership to co-design implementation of WH in HIV specialty care. Co-design is a novel
participatory method that goes beyond traditional engagement strategies, like research interviews, by including
end users as equal members of the team. We will identify and work with key stakeholders in HIV specialty care
(e.g., Veterans, HIV providers and leadership) to co-design a WH implementation blueprint, detailing core
implementation features (e.g., the actors in implementation efforts, the actions they take, the targets of their
actions, the timing of these actions). Moreover, because the intersection of aging, vulnerability and stigma are
emblematic of challenges to caring for many Veteran populations, our blueprint can serve as an exemplar to
coordinating a WH approach across VA primary and specialty care settings, truly offering the systems
approach envisioned by VA.
Specific Aims: We will develop a WH implementation blueprint through the following aims: 1) Understand the
extent to which Veterans with HIV are currently receiving WH care at the 18 WH Flagship sites. 2) Examine
providers’ and Veterans’ perspectives on WH Clinical Care to learn how they think WH can be implemented in
HIV specialty care settings. 3) Working with key stakeholders - Veterans with HIV, HIV providers and
leadership - co-design a blueprint for WH implementation in HIV specialty care settings.
Methodology: This three-year study uses a mixed-methods design. Aim 1 uses administrative and survey
data to quantitatively describe the receipt and use of WH by Veterans with HIV. Aim 2 uses semi-structured,
qualitive interviews to explore HIV providers’ and Veterans’ views of WH with attention to strategies that might
support or undermine a WH approach to HIV clinical care. Aim 3 uses co-design methods to bring together an
expert panel of Veterans and HIV providers, identified in Aims 1 and 2, and leadership.
Next Steps/Implementation: Our blueprint will provide the Office of Patient-Centered Care and Cultural
Transformation a pragmatic guide to help VA facilities determine how to implement WH in specialty care.

Public health relevance
PROJECT NARRATIVE Goal 2 of VA's Vision Plan is to "deliver comprehensive and integrated Whole Health care," where a holistic, patient-centered approach is part of all interactions across the healthcare system. However, implementation has been focused in primary and mental healthcare settings, with little attention to specialty care, like HIV clinics. Veterans living with HIV are likely to benefit from a Whole Health approach because of their complex health and social needs. A plan for HIV specialty care implementation is thus needed. We will identify and then work with Veterans with HIV and their HIV providers, as well as leadership, to co-design an implementation blueprint for HIV specialty care. Findings will provide an example of how to provide patient-centered care throughout the VA healthcare system.